Nucleophilic Halogenation Reagents

A 1260 II UHPLC with 8-column switching valve, a quaternary pump, autosampler, high sensitivity diode array (DAD) and 8 column switching valve is requested to replace an 18-year old Waters HPLC, which cannot keep up with our current demands in the research area of halogenation reagents and conditions that include exploring stereoselective halogenation approaches and F18. The quote from the manufacturer is $ 59,703.38

Public health relevance
In the first year of the NIH award my group produced six papers and a five conference presentations., described in our first year report, last October. Since then, we have published--in only 7 months--a total of six new papers in top-rated journals, including one JACS, one Angewandte, one ACS Catalysis and one Organic Letters (all listed below). We have also submitted a patent application for a technology described in our JACS paper (publication #6). The fast-paced chemistry that we are engaged on has overrun the limits of our current HPLC Waters unit, which was bought in 2004 (18 years ago). Especially, now that we are interested in exploring the enantioselective applications of our halogenation protocols we want to purchase an Agilent HPLC system. It is a 1260 II UHPLC with 8-column switching valve, a quaternary pump, autosampler, high sensitivity diode array (DAD) and 8 column switching valve. This unit delivers pressures up to 600 bar. Its pulse-free, stable and well- mixed gradients ensure higher sensitivity and more reliable results . The unit has access to up to four solvents, giving great flexibility in automated solvent blending for a wide range of research applications. The InfinityLab Poroshell 120 columns provide fast, rugged, high-resolution separations. High-sensitivity flow cells for the diode array detector will allow us to detect the weakest sample concentrations.